Parent-child neurobehavioral synchrony and early ADHD symptom trajectories

Project Summary/Abstract
Attention-Deficit/Hyperactivity Disorder (ADHD) is the most common neurodevelopmental disorder and is
associated with significant social, educational, and health impairments. Symptoms of ADHD are often present
at preschool age with more than half of children at age 3 (including those with subthreshold symptoms)
meeting full diagnostic criteria later in childhood. Current treatments administered after ADHD diagnosis do not
ameliorate long-term dysfunction. Early identification and intervention targeting neural networks implicated in
attention during the preschool period, a sensitive period of brain development when ADHD symptoms begin to
emerge, may improve symptom trajectories and long-term outcomes. The current study builds upon existing
research on the aberrant (weakened resting state) neural connectivity of the frontoparietal network (FPN)
among children with ADHD and the influential role of parent behavior on children’s development of attentional
control and neural network organization that supports higher order executive functioning. Our team has found
that alterations in developmental patterns of FPN connectivity during parental engagement are detectable
amongst young children with elevated symptoms before ADHD can be reliably clinically diagnosed. Moreover,
our research using functional Near Infrared Spectroscopy (fNIRS) suggests that synchronous brain activity
between parents and children may strengthen self-regulation skills (such as attentional focusing). Thus,
research identifying the potential to target parent-child behavior, and its implications for brain development
supporting attentional focusing, may uncover ADHD prevention opportunities. Thus, using fNIRS, this study will
examine the associations between parent-child focused attention, parent-child neural synchrony (PCNS), and
child resting state FPN connectivity in relation to ADHD symptom trajectories among 210 preschool-aged
children (3-4 years). The sample will be enhanced for risk of developing ADHD (2/3 with 4+ ADHD symptoms).
Children will be followed longitudinally for 2 years with ADHD symptoms and impairment assessed every 6
months through the transition to school age (5-6 years) to examine neural and behavioral predictors of early
ADHD symptom trajectories. Finally, to begin to identify potentially malleable parenting behaviors that would
support the development of future preventive interventions, we will microcode parenting behavior during a
parent-child interaction task and examine, using time-series analyses, which behaviors are antecedents to
PCNS and child focused attention. Teaching parents to interact with their children in a way that enhances
neural synchrony may strengthen FPN connectivity and dampen development of ADHD symptoms and
impairment. This project has the potential to make transformative gains in the understanding of the
neurodevelopment of childhood ADHD and pave the way for early preventive interventions before the onset of
full symptoms and associated impairment.

Public health relevance
Narrative Attention-Deficit/Hyperactivity Disorder (ADHD) is a common neurodevelopmental disorder that significantly impacts academic, social, and health outcomes and is frequently identified at school age after impairment is present. Attention develops rapidly over the first 5 years of life and is influenced by social interactions; thus, increasing the quality of early parent-child interactions may enhance brain connectivity in regions responsible for sustaining attention. We propose to use functional near infrared spectroscopy (fNIRS), a non-invasive, wearable, brain imaging technique, to examine the relationship between parent-child brain and behavior synchrony and ADHD symptoms from preschool to school age to begin to explore the impact of parenting behaviors on child brain development with results having potential implications for ADHD prevention.